Nicotinic Modulation of the Cognitive Control System in Late-Life Depression

PROJECT SUMMARY: Deficits in cognitive control are core features of late-life depression, contributing both
to emotion dysregulation and problems with inhibiting irrelevant information, conflict detection, and working
memory. Clinically characterized as executive dysfunction, these deficits are associated with poor response to
antidepressants and higher levels of disability. Improvement of cognitive control network (CCN) dysfunction
may benefit both mood and cognitive performance, however no current pharmacotherapy improves CCN
deficits in LLD. Supported by our pilot data, we propose that nicotine acetylcholine receptor agonists enhance
CCN function and resultantly improve mood and cognitive performance in late-life depression. The objective
of this R61 / R33 proposal is to first determine whether transdermal nicotine enhances CCN neural activity in
an exposure-dependent fashion during an emotional response inhibition task (the emotional Stroop task). If we
meet our Go Criteria by demonstrating exposure-dependent CCN target engagement, we will then conduct the
R33 pilot randomized controlled trial to: 1) determine the relationship between target engagement and clinical
improvement; 2) examine the specificity of transdermal nicotine’s effects on the CCN; and 3) obtain preliminary
evidence of TDN’s clinical effects. The long-term goal of this line of research is to determine whether nicotinic
acetylcholine receptor agonists enhance CCN function and provide clinical benefit to individuals with late-life
depression. Supported by our pilot data, this project’s rationale is that it will elucidate whether broad nicotinic
acetylcholine receptor agonists enhance CCN activity and if so, does that mechanism positively influence
clinical symptoms. A negative finding will improve our understanding of the neural effects of broadly active
nicotinic receptor agonists and whether targeting the CCN has therapeutic benefit. Our approach for the R61
phase is to examine in 36 older adults with Major Depressive Disorder whether transdermal nicotine patches
enhance CCN activity over 12 weeks as measured during fMRI with the emotional Stroop task while measuring
nicotine and nicotine metabolite levels. If we meet Go Criteria by demonstrating exposure-dependent target
engagement, we will proceed to the R33 pilot clinical augmentation trial. Seventy-two depressed elders on
stable SSRI or SNRI monotherapy will be randomized to 13 weeks of active transdermal nicotine or placebo
patches, completing MRI and cognitive testing at baseline and at the trial’s end. Dosing will be guided by
nicotine blood levels and based on the relationship between exposure and target engagement as observed in
the R61 phase. This proposal is significant and innovative as no current pharmacotherapy improves CCN
function or improves cognitive deficits in late-life depression. Transdermal nicotine has a mechanism of action
that is distinct from current antidepressants, potentially making it an important augmentation agent. If our
hypotheses are correct, as patches are commercially available, this approach could be rapidly moved into
definitive studies and may have applicability to other psychiatric disorders characterized by CCN dysfunction.

Public health relevance
PROJECT NARRATIVE This study will examine the effect of transdermal nicotine on cognitive control network function and depression symptoms in older adults with late-life depression. This will advance our understanding of whether or not modulation of cognitive control network function leads to clinical improvement in depression. If our hypotheses are correct, nicotinic receptor agonists may develop into an important antidepressant augmentation strategy.